Mechanism-based serum biomarkers and validation of ensemble model for excessive alcohol use

Project Summary
Increasing the sensitivity and specificity of biomarkers for recognizing recent, excessive alcohol use (EAU) in
Veterans is a timely goal of research. EAU is becoming recognized as an emerging health-related problem
especially among veterans returning from combats. As such, there is a need for increased vigilance and action
to identify and counsel at-risk veterans. The diagnosis and care of veteran patients with EAU is hampered by
the lack of tests with high diagnostic performance that can detect dangerous levels of drinking or relapse
during therapy. Such tests would be indispensable for screening and care for veterans with EAU. The
consequences of under-detection of EAU, thus delayed intervention are serious because relative risk of alcohol-
related health conditions is increased with the amounts and duration of alcohol consumed per day. Excessive
alcohol use (EAU) is becoming recognized as an emerging health-related problem especially among veterans
returning from combats. Our preliminary data using the new landscape of proteomic and transcriptomic
approaches have uncovered the pathophysiology of EAU on several pathways; which might lead to
pathology in human. This renewal CSR&D Merit Review Award application seeks the support to define
the roles of the panels of biomarkers; derived from the effect of EAU on inflammatory response to screen
for EAU and quantity of recent alcohol consumption and monitoring for abstinence. We hypothesize that
(i) these biomarkers derived from system biology analyses are useful and have a better diagnostic performance
to screen for EAU and the quantity of recent alcohol consumption in clinical practice, when compared to the
conventional markers and (ii) the combination of these markers into a single risk model prediction using
machine learning and statistical mechanics will revolutionize the way we screen for EAU in clinical practice. To
test this hypothesis, we plan to pursue the following specific aims; SPECIFIC AIM # 1: Determine the effect of
EAU on organ system identified by system biology approach and by detecting, identifying, and comparing the
relative quantity of these novel targets as potential biomarkers for EAU, and SPECIFIC AIM # 2: To develop
and validate of a risk model for prediction of EAU combining aspects of machine learning and statistical
mechanics. If successful, the results from this project will revolutionize the screening methods for veterans
with excessive alcohol use.

Public health relevance
Project Narrative Drinking becomes excessive when it causes or elevates the risk for alcohol-related problems or complicates the management of other health problems. The alarming prevalence of excessive alcohol use (EAU) among veterans is concerning and the vigilance and action to identify veterans with EAU is of importance. The consequences of under-detection of EAU, thus delayed intervention are serious because the potential consequence of adverse alcohol-related health conditions is increased with the quantity and duration of alcohol consumed. In this application, we propose to systematically study novel and mechanism-based biomarkers as the screening tool for EAU. Further, we will determine the diagnostic performance of a risk model for EAU prediction using statistical mechanics.